GLO1/Aβ-mediated mitochondrial and synaptic injury in Alzheimer's disease

Summary
Mitochondrial dysfunction and synaptic damage are early pathological features of Alzheimer’s disease (AD)-
affected brain1-5 and aging brains. Memory impairment in AD is a manifestation of brain pathologies such as
accumulation of amyloid-β peptide (Aβ) and mitochondrial damage. The underlying pathogenic mechanisms and
effective disease modifying therapies for AD remain elusive. Age is a strong risk factor for the onset and
progression of AD, particularly late-onset AD. Age-related metabolic changes increase generation and deposition
of toxic metabolites such as glucose-derived methylglyoxal (MG) and advanced glycation endproducts (AGEs)
Glyoxalase 1 (GLO1) is a key/initial enzyme responsible for eliminating and
detoxifying MG to prevent the formation of AGEs. So far, little is known about the role of GLO1 on Aβ-induced
mitochondrial and amyloid pathology, neuroinflammation, synaptic and cognitive dysfunction in AD and AD-
linked mouse models
in AD- and Aβ-affected brain.
. It is unclear whether neuronal GLO1 is mechanistic linker between mitochondrial
dysfunction and neuroinflammaton and synaptic injury and if gain of neuronal GLO1 could alleviate amyloid
We hypothesize
that in AD superimposed Aβ, excessive accumulation of MG/AGEs and impaired GLO1 function serve
to accelerate and exaggerate amyloid pathology, leading to mitochondrial
and synaptic stress, thus, clearance of Aβ and AGEs by gain of GLO1 may be of importance in preventing
pathology and synaptic and cognitive dysfunction and slow down disease progression in AD.
as
causative endogenous danger signals
amyloid and mitochondrial pathology. Utilizing novel gain-of-function neuronal GLO1 mice in AD mouse model
and multi-color two-photon in vivo imaging to simultaneously visualize excitatory and inhibitory synapses in the
same neurons, we will explore new mechanism underlying GLO1-dependent Aβ metabolism and mitochondrial
alterations and address whether GLO1 signaling is protective or destructive to neurons in amyloid pathology to
fully establish the benefits/pitfalls of enhancing GLO1 as a therapeutic strategy in AD.

Public health relevance
Narrative The aim of this project is to investigate a role of mitochondrial glycation and glyoxalase 1(GLO1) in amyloid and mitochondrial and Aβ pathology, synaptic function, and neuroinflammtion and to elucidate the link between mitochondrial dysfunction and innate immune and inflammatory response and their contribution to amyloid pathology and synaptic injury. The outcomes of the proposed studies would also support that GLO1 might be a potential new therapeutic agent for limiting amyloid accumulation and improving mitochondrial and synaptic function.